Mechanisms and evolutionary consequences of transposon strategies to counteract host silencing

PROJECT SUMMARY
Harboring active transposable elements (TEs) imposes a substantial mutational burden on the host genome. To
reduce this burden, most organisms have evolved sophisticated, and often multi-layered, mechanisms for
identifying and inactivating TEs. In spite of these defenses, active TEs are found in the genomes of almost all
eukaryotes. One explanation for the evolutionary persistence of TEs is that they are in an “arms race” with their
host genome: TEs are constantly evolving novels ways to block or evade host silencing while the host genome
is continuously evolving to re-establish TE suppression. While this theory is appealing, there is a gap in
knowledge because the mechanisms by which TEs could block or evade host defenses are largely unknown.
The long-term goal of this applicant’s laboratory is to understand the evolutionary dynamics of TE/host co-
evolution. The overall objective of this project is to understand and functionally validate a novel TE strategy,
discovered in the applicant’s laboratory, that involves TEs using their own piRNAs to target host silencing factors
for suppression. Preliminary data produced in the applicant’s laboratory suggests that the Drosophila
melanogaster telomeric transposon TART-A captured a portion of the host TE silencing factor nxf2, which allows
TART-A to produce piRNAs targeting nxf2 for suppression. The rationale for the proposed research is that it will
provide critical insight into the mechanisms of host-TE conflict and how TE counter-defense strategies can
impact host gene expression and fitness. The objective of this project will be achieved by pursuing three specific
aims: 1) Identify genes acquired by telomeric TEs across Drosophila; 2) Determine whether non-telomeric
transposons also use a piRNA-mediated counter-silencing strategy; and 3) Disrupt TE counter-silencing using
CRISPR in D. melanogaster. Telomeric TEs will be identified in 28 species of Drosophila and assayed to
determine whether they have acquired host gene fragments. The applicant’s laboratory has identified 45
candidate genes in D. melanogaster that share homology with TE-derived piRNAs and are known to play a role
in TE suppression. These genes will be tested to determine if they suppress the same TE with which they share
homology. Candidate TE/gene pairs will be validated using CRISPR genome editing to erase their shared
homology, which should result in upregulation of the gene in question. The proposed research is innovative
because it represents a substantial departure from the status quo: instead of the host-centric view of previous
studies, which examine how the genome responds to TE activity, this project will study the TE side of the equation
by investigating how TEs respond to and counteract host defenses. One of the major goals of the field is to
understand why host genes involved in TE silencing are rapidly evolving. The proposed research is significant
because it will support this goal by characterizing and functionally validating a specific TE counter-defense
strategy, which will provide empirical support for the arms race theory, while also increasing understanding of
the co-evolutionary dynamics between host genomes and their TE associates.

Public health relevance
PROJECT NARRATIVE This project seeks to understand how selfish genetic elements known as transposons are able to remain active in the genomes of most organisms despite the existence of highly specialized pathways used by host genomes to identify them and suppress their activity. The research proposed here is relevant to human health because mutations created by transposons are responsible for over one hundred mendelian diseases in humans. Understanding how transposons are able to avoid being silenced by their host could lead to novel interventions to reduce transposon activity, thereby supporting the NIH’s mission to enhance health and reduce illness.